Heterozygous SERPINE1 Deficiency Confers Durable Cardiovascular Fitness in Humans

SUMMARY. The number of Americans over age 65 years is growing and is projected to increase from
approximately 39 million in 2010 to an estimated 71 million in 2030. The prevalence of multi-morbidity, including
cardiovascular disease, Alzheimer's dementia, emphysema, and diabetes increases significantly with age. One
of the best validated molecular fingerprints of aging and senescence is the protein plasminogen activatorinhibitor-
1 (PAI-1) (the protein product of the gene SERPINE1). A remarkably robust and consistent body of experimental
evidence generated by laboratories from around the world have identified a mechanistic link between PAI-1 and
aging-like pathology in every major organ system, including the heart, kidney and skin among others. In healthy
human populations, higher levels of PAI-1 are associated with coronary artery disease, increased vascular
stiffness, obesity, diabetes, fatty liver disease, and emphysema/obstructive lung disease. Conversely, PAI-1
deficiency and/or pharmacological inhibition of PAI-1 provides substantial protection against aging-like
cardiovascular pathology in mice. The protective effect of PAI-1 deficiency on biological aging appears to be
operational in humans. In a geographically and genetically constrained community of Old Order Amish, a
remarkable “natural” experiment has been underway for 8 generations. This community harbors a private loss-
of-function (LOF) mutation in SERPINE1, that can be traced back to a single ancestor that married into the
community in the late part of the 19th century. Heterozygous carriers of the null mutation in SERPINE1 have
longer telomeres, lower fasting insulin levels, protection from diabetes, preserved vascular flexibility, and a longer
life span than their unaffected kindred. In this proposal, we will test the hypothesis that lifelong PAI-1 deficiency
provides multifaceted protection against cardiovascular aging. This application is designed to investigate the
pleiotropic effects of PAI-1 on cardiovascular resilience and aging and reveal the molecular mechanisms that
explain these effects. These studies will leverage the only known kindred in the world with a naturally occurring
loss-of-function variants in PAI-1 with experimental studies in mice and in iPSC-derived vascular cells to translate
the generalizability of these findings. We anticipate that the studies proposed here will advance our
understanding of the pivotal role of PAI-1 in aging-related cardiovascular disease, the molecular mechanisms
that explain this relationship, and provide proof of principle that pharmacological inhibition of PAI-1 is a rational
therapeutic approach in preventing aging-related cardiovascular morbidity in humans.

Public health relevance
NARRATIVE Aging is associated with the loss of resilience and reparative potential at the cellular level and is the most powerful risk factor for the development of cardiovascular disease. While most of the known risk factors for CV disease are susceptible to contemporary therapeutic or lifestyle interventions, there is no specific therapy that slows, prevents or reverses the impact of age on the cardiovascular system. We have assembled an integrated proposal and a multidisciplinary team to investigate systematically the pleiotropic effects of lifelong PAI-1 deficiency on cardiovascular aging. We anticipate that the studies proposed here will advance our understanding of the pivotal role of PAI-1 in aging-related cardiovascular morbidity, the molecular and epigenetic mechanisms that explain this relationship, and provide proof of principle that pharmacological inhibition of PAI-1 is a rational therapeutic approach in preventing aging-related cardiovascular disease in humans.